A novel nuclear role for smooth muscle alpha-actin

ABSTRACT
Pathogenic variants in ACTA2, which encodes smooth muscle α-actin (SMA), are a major cause
of heritable thoracic aortic disease, and missense variants affecting two specific amino acids of
ACTA2 (arginines 179 and 258; R179 and R258) also predispose to moyamoya disease (MMD).
MMD is characterized by narrowing and occlusion of the distal internal carotid arteries, and is a
common cause of pediatric-onset strokes. Multiple genetic factors predisposing to MMD have
been found, but there is no identified common mechanism of pathogenesis. However, pathology
from affected vessels suggests that smooth muscle cell (SMC) proliferation and migration may
drive the disease. We found a common molecular defect between R179 and R258 ACTA2
variants not shared by other ACTA2 variants: a loss of nuclear SMA function. Based on our
preliminary data, we hypothesize that nuclear SMA is critical for differentiation of cerebrovascular
SMCs from neuro-ectodermal progenitor cells, and that incomplete differentiation of SMCs primes
the cells for the excessive proliferation and migration that causes MMD. We are focusing on
ACTA2 p.R179 variants because these patients have the most severe and earliest-onset disease.
We will test our hypothesis with the following specific aims: 1) Using our conditional smooth
muscle-specific knock-in Acta2SMC-R179C/+ mouse, we will assess cell fate trajectories of wild-type
and heterozygous Acta2 p.R179C mutant SMCs over developmental time using single cell RNA-
sequencing. 2) We will use Crispr/Cas9 to correct the pathogenic variant in induced pluripotent
stem cells (iPSCs) from ACTA2 p.R179 patients (n=3) and assess whether gene editing restores
the SMC differentiation potential of these cells; we will also generate sequencing and integrated
bioinformatics analyses to interrogate chromatin remodeling changes during differentiation that
are reliant on nuclear SMA. 3) We will investigate the role of chromatin remodeling protein EZH2
in the incomplete differentiation phenotype of Acta2 p.R179 cells, including testing an FDA-
approved inhibitor of EZH2 as a potential therapeutic in our mouse model. Successful completion
of these aims will provide clear data on epigenetic remodeling required for SMC development and
how that development is perturbed by ACTA2 p.R179 variants. These data will also establish the
potential efficacy of EZH2 inhibitors as a treatment for patients with ACTA2 p.R179 variants, and
future studies will explore applicability of this treatment for patients with other pediatric MMD-
associated pathogenic variants. Finally, these data should identify molecular regulators of SMC
cell fate specification, which could lead to promising avenues for future research on the
maintenance of SMC identity across multiple vascular diseases.

Public health relevance
PROJECT NARRATIVE Moyamoya disease (MMD), characterized by bilateral progressive stenosis and occlusion of the internal carotid arteries, is a common cause of stroke in children, and we propose that lack of differentiation of smooth muscle cells (SMCs) is the causative pathologic mechanism. A pathogenic prevents The SMC prospective complications specific amino acid change in the smooth muscle α-actin ( SMA protein causes MMD and nuclear localization of SMA, l eading to an incompletely differentiated SMC phenotype. proposed studies will address the mechanisms linking loss of nuclear SMA with incomplete differentiation, which will provide new insights into SMC development, and will test treatment strategies that can restore SMC phenotype and potentially prevent clinical in young patients with these SMA variants. )